The Neuroimmunology of Depression in Women Living With HIV

PROJECT SUMMARY / ABSTRACT
In response to RFA-DA-21-116, “Mood Disorders in People Living with HIV: Mechanisms and Pathways”,
we
propose to investigate neuroimmunological and reward functions to study comorbid depression in women living
with HIV (WLWH), a group heavily impacted by depression and its health consequences, yet underrepresented
in HIV research. The proposed research will build upon the established Multicenter AIDS Cohort Study
(MACS)/Women’s Interagency HIV Study (WIHS) Combined Cohort Study (MWCCS) (Dr. Sharma, MPI of Bronx
MWCCS) and its unique cohort of phenotypically well-characterized women with and without HIV. Our proposed
model is: (1) HIV infection induces systemic inflammation (cytokines, kynurenines); (2) systemic inflammation
extends to the CNS inducing oxidative stress [↓glutathione (GSH, antioxidant)] and gamma-aminobutyric acid
(GABA, major inhibitory neurotransmitter) deficits; (3) such neurochemical changes alter the reward circuitry,
which contribute to the high prevalence of depression in WLWH. In support of this model, our immunological
work in the WIHS found increased kynurenine pathway (KP) activity in WLWH compared to women without HIV,
and among WLWH, KP activity was higher in WLWH with depression. In our depression non-HIV research, we
found that anhedonia–a core symptom of depression reflecting reward deficits–was associated with worse
depression outcomes, including chronicity and suicidality. To better delineate reward circuitry, we identified
distinct resting-state network features associated with depression and anhedonia using striatal-based intrinsic
functional connectivity and whole-brain parcellation data-driven graph theory analysis. We additionally utilized
the reward flanker (RFT) and reward prediction error (RPET) fMRI tasks to examine distinct brain activity during
reward anticipation, attainment, and prediction errors, which predicted future depression severity. Utilizing proton
MR spectroscopy, we showed that anhedonia accounted for decreased anterior cingulate cortex (ACC) GABA
levels in adolescent depression, and moreover, we documented inverse relationships between cortical GSH and
anhedonia severity in depressed adults. Furthermore, we reported associations between circulatory cytokines
and kynurenines with both anhedonia and reward neurocircuitry in youth. Extending our compelling findings, we
will now test the overall hypothesis that WLWH exhibit increased systemic and CNS inflammation, which leads
to reward dysfunction and subsequently depression. We will utilize a 2×2 factorial design: 1) 100 depressed
WLWH; 2) 100 non-depressed WLWH; 3) 50 depressed HIV negative women; and 4) 50 non-depressed HIV-
negative women. Participants will have comprehensive evaluations at baseline, 6- and 12-months assessing
depression, reward, anxiety, trauma, HIV treatment, CD4+ count, and VL. F-MRI (resting-state, RFT, RPET), 1H
MRS (GABA, GSH), a reward computerized task and cognitive tests will be done at baseline.

Public health relevance
PROJECT NARRATIVE We propose to investigate neuroimmunological and reward functions to study comorbid depression in women living with HIV (WLWH), a group heavily impacted by depression and its health consequences yet underrepresented in HIV research. This collaborative proposal bridges disciplines of depression, neuroimaging, HIV, and metabolomics in an effort to improve our understanding of neural mechanisms underlying depression in WLWH and has the potential to improve overall and mental health outcomes in this highly vulnerable group.